Career Training in the Biology of Aging

Project Summary
The Career Training in the Biology of Aging training program provides graduate students and post-doctoral
fellows with a comprehensive, in-depth research training in aging biology, which emphasizes logical and con-
ceptual thinking, together with career-oriented mentoring designed to promote success in a diverse professional
landscape. Aging biology has a long and proud history at the University of Michigan (UM), which is one of the
top Universities in the world with institutional support for aging research that is at an elite level. The Geriatrics
Center is recognized internationally for clinical, educational, and research programs, and it provides an out-
standing setting for our Training Program. The program benefits from a Claude Pepper Older Americans Inde-
pendence Center, the Ann Arbor VA GRECC (Geriatrics Research, Education, and Clinical Center), the Michigan
Biology of Cardiovascular Aging program, and the Paul F. Glenn Center for Aging Research. Our preceptors
are a diverse, highly interactive, well-funded, and creative group that span 15 different departments/programs
and four schools at UM. As a group we have recruited promising junior faculty members to our program and
expanded our national recognition through individual faculty awards and institutional support (e.g., the Glenn
Laboratories designation and $12m investment from the Medical School to recruit six new faculty members in
aging biology). The popularity and success of our program has seen a doubling of candidate trainees over the
past decade, which has enabled us to appoint highly qualified trainees to each of our training positions every
year, consisting of 6 pre-doctoral and 3 post-doctoral training positions. Our program has long emphasized hy-
pothesis-based laboratory training through creative and impactful research, and we have proactively enriched
these experiences with successful initiatives that have enhanced diversity, provided exposure to broad career
opportunities, promoted synergy between the pre- and post-doctoral trainees, and stimulated relationship
building with our extensive alumni network. As a result, our trainees have enjoyed tremendous success across
the professional landscape, and they have been well positioned for the explosion of public and private interest in
aging biology. While continuing our successful Biogerontology Research Seminars, Journal Clubs, and Research
Symposia, we have implemented new career-oriented initiatives, such as the development of our Aging Buddies
Mentorship program, which matches current trainees with like-minded alumni who have succeeded in distinct
career paths. These additions complement successful efforts in mentorship including Certificate Programs that
provide enhanced training in areas such as teaching, public policy, and entrepreneurship; integrated Individual
Development Plans; summer workshops on coding, statistical rigor, and science writing; mentorship committees
for our post-doctoral trainees and junior faculty; extensive training in the responsible conduct of research; and
focused efforts to recruit and retain a diverse trainee population, which has nearly quadrupled diversity in the
program over the past decade.

Public health relevance
Project Narrative We propose a comprehensive training program in the biology of aging that will prepare trainees for careers at the forefront of academics, industry, biotechnology, and entrepreneurship, thereby promoting the discovery of a deeper biological understanding of the aging process and nurturing a passion to apply their experiences, in lab, clinic, and innovation spaces to alleviate the cost and suffering associated with age-related disease.